HSR&D Research Career Scientist Award

PROJECT SUMMARY
Dr. Martin is an accomplished researcher, a widely known expert and a national leader in the field of sleep
health and sleep disorders in Veterans. Her seminal work in sleep in older adults has been widely recognized,
and her expanding portfolio of studies on sleep disorders among women Veterans is at the cutting edge of
national research priorities. Her methodological contributions in the area of wrist actigraphy spans two decades
and has led to innovations in analysis and interpretation in both research and clinical settings. Insufficient and
poor quality sleep resulting from sleep disorders can have a negative impact on health outcomes and quality of
life for Veterans. This is particularly true for patient populations who are at risk for poor outcomes. While there
are established treatments and best practices for management of sleep disorders, including sleep apnea and
insomnia, significant knowledge gaps remain in how best to manage complex patients and improve patient-
centered outcomes.
The goal of this application is to provide support for an established investigator to expand her current line of
research on these two common diseases, with a focus on subgroups of Veterans who are most at risk for the
negative consequences of poor sleep. Dr. Martin has a track record of mentoring trainees at multiple levels
toward research independence, and extensive collaborations with other investigators and VA agencies,
including the Office of Mental Health and Suicide Prevention. The proposed award will enhance her ability to
provide additional mentoring to promising early-career VA investigators, and enable her to embark on new and
innovative areas of investigation related to sleep disorders and sleep health among Veterans.

Public health relevance
NARRATIVE The proposed Research Career Scientist Award will support Dr. Martin’s active research program studying sleep disorders among Veterans and her mentorship of early-career researchers in sleep science. The protected time provided by this award will allow her to build upon her track record of research success and notable impacts. VA will benefit from Dr. Martin’s ongoing program of health services research focused on sleep health and sleep disorders among Veterans.